RECOVERY OF FUNCTION FOLLOWING NEURAL DAMAGE

This proposal is designed to examine recovery of function after damage to the adult nervous system, using the sympathetic innervation of the rat pineal gland as a model system. The pineal gland is innervated by both superior cervical ganglia, and this innervation can be reproducibly denervated or decentralized, either totally or partially. In addition, the activity of the pineal enzyme serotonin N-acetyltransferase (NAT) is highly dependent on sympathetic nerve stimulation and can be used as an index of the recovery of synaptic transmission. The pineal gland thus offers certain experimental advantages for studying neural plasticity; however, the results obtained will be relevant to other sympathetic pathways and to other parts of the nervous system. The aim of this research will be not only to elucidate the anatomical and biochemical changes which arise in response to neural damage (for exmaple, regenerative and collateral sprouting and postjunctional supersensitivity) but also to assess the extent to which these changes restore or inhibit normal function. Four main areas will be emphasized: (1) studies of regeneration of the sympathetic innervation of the pineal gland after bilateral denervation, (2) a comparison of the effects of bilateral decentralization and bilateral denervation, (3) an evaluation of the hypothesis that "heteroneuronal uptake" of neurally released transmitter (i.e., uptake by neurons other than the neurons which released the transmitter) is responsible for the permanent impairment of pineal function after unilateral decentralization, and (4) an examination of the physiological importance of the development of "disuse" postjunctional supersensitivity in the pineal gland. A variety of anatomical, physiological, and biochemical techniques will be used including retrograde "double-labeling" of neuronal cell bodies, visualization of catecholamine varicosities using the glyoxylic acid method, direct electrical stimulation of specific sympathetic nerve trunks, and measurements of NAT, melatonin, and cAMP levels. These studies are designed to increase our knowledge of the basic mechanisms underlying plasticity in the adult nervous system. As such, they will be relevant to our understanding of factors promoting and limiting the recovery of function after neural damage, such as that caused by stroke, trauma and degenerative neurological disease.